Project 3: Multi-modal phenotypic Characterization of marmoset models of Late Onset Alzheimer's Disease

PROJECT SUMMARY PROJECT 3
Project 3: Comparative Multimodal Phenotypic Characterization of Marmoset Models of AD
Alzheimer’s Disease (AD), the most common cause of dementia, is a multifactorial neurodegenerative disorder
affecting ~6 million Americans. Currently, there are no interventions capable of preventing, stopping, or treating
AD. The scarcity of adequate animal models that enable a comprehensive investigation of the pathogenic
mechanisms at play in AD has limited our progress towards discovering effective treatments. There is a critical
need for enhanced animal models that incorporate genetic variability, optimal lifespan to support age-related
research, superior compatibility as a model of human social and cognitive behavior, and the presentation of AD-
related pathology. The central premise of our Consortium “Generation, Characterization, and Validation of
Marmoset Models of Alzheimer’s Disease” (MARMO-AD) is that the marmoset will reveal the earliest primate-
specific cellular and molecular root causes of AD pathogenesis and progression. We postulate that marmosets
engineered to harbor genetic risk variants for early- (EOAD) and late-onset AD (LOAD) will reveal clinical disease
trajectories that model those of human AD patients and display primate-specific disease pathogenesis that can
be detected with a comprehensive phenotypic characterization pipeline. We hypothesize that: (1) the
comprehensive assessment of genetic, molecular, functional, behavioral, and pathological phenotypes in
marmosets will provide translatable knowledge of the origins and progression of AD in human populations; and
(2) the comparative, longitudinal study of the marmoset LOAD model against the EOAD models and healthy
controls will identify emerging phenotypes that precede frank neuropathology and prioritize tractable targets for
future therapeutic discovery. The ATP-binding cassette, sub-family A, member 7 (ABCA7) gene was identified
by genome-wide association studies (GWAS) as having one of the highest odds ratios for developing LOAD in
humans. In this project, we will create a novel genetically engineered marmoset LOAD model incorporating an
ABCA7 LOAD variant. Once these animals are born, we will follow them longitudinally to identify emerging
phenotypes that deviate from healthy aging ahead of the appearance of frank neuropathology. We will evaluate
non-carrier healthy control marmosets to characterize the typical healthy aging trajectory across the lifespan and
establish a baseline against which we can contrast our marmoset models of LOAD and EOAD. We will then
evaluate the disease trajectory of the ABCA7 marmoset LOAD model relative to the PSEN1 EOAD models via
longitudinal, multimodal phenotypic characterization in line with the clinical staging of AD patients. By contrasting
our marmoset models of EOAD and LOAD, we hope to identify differential biomarkers of LOAD that can be
measured ahead of the emergence of frank neuropathology and prioritize novel targets for therapeutic
development. Upon validation of these unique primate AD models, we plan to expand the colony and share this
precious resource with the greater AD research community to help accelerate the pace of bringing novel and
effective treatments to patients.